Exploring Preteens' Understanding of Death and Suicide: Age-Related Differences and Implications for Suicide Assessment

PROJECT SUMMARY
Suicide is a leading cause of death for youth in the United States and is notoriously difﬁcult to assess, predict,
and treat. Recent United States trends indicate preteen youth are dying by suicide at an alarming rate;
however, little is known or understood about how children conceptualize death by suicide. This has made it
difﬁcult to determine if traditional approaches to suicide assessment, which typically presume respondents'
clear understanding of suicide, are developmentally appropriate for preteen youth. Thus, research on preteens'
understanding of suicide and death warrants further study and may have important implications for clinical
assessment and intervention. The proposed study will examine how preteen youth uniquely perceive death
and suicide, and how such perceptions relate to responses on traditional suicide assessments. Speciﬁcally, we
will examine age-related differences in understanding of death (Aim 1), test whether preteen understanding of
death is dependent on the cause of death (Aim 2), and explore how preteens with suicidal thoughts and
behaviors conceptualize death (Aim 3). Self-report data on death conceptualizations and traditional suicide
assessments will be collected from two research studies examining suicide among preteen youth. Both studies
will employ a newly developed measure designed for preteens, the Continuity of Functioning After Death
Interview (CoFAD), to assess biological and non-biological domains of death and suicide. Traditional self-
report measures will be used to evaluate for the presence of suicidal ideation. Results will offer the
foundational understanding needed to create more developmentally appropriate suicide assessments and may
uncover malleable intervention targets addressing preteen suicide.

Public health relevance
PROJECT NARRATIVE Preteen youth are dying by suicide at an alarming rate in the United States, however, traditional suicide assessments were not designed with preteens in mind and presume respondents' clear understanding of suicide. The current study therefore examines how preteens uniquely perceive foundational concepts such as death and suicide. Results will inform the design of more developmentally appropriate preteen suicide assessments while also potentially uncovering malleable intervention targets.